Optoanesthesia

DESCRIPTION (provided by applicant): The alkylphenol anesthetic propofol is used in millions of surgical and noxious procedures annually. While the clinical use of propofol has swelled, mechanistic understanding of its many actions, on all levels, has lagged behind. In this proposal, we will deploy our photoactive alkylphenol analogues of propofol, azi-propofol-m (aziPm) and 2-propynloxymethoxy-5-trifluoromethyldiazirinylphenol (aziPm-click), in a tiered series of studies to reveal: the photoactive alkylphenol binding proteome using state-of-the-art mass spectrometry and enrichment methods (aim 1), the electro- physiological character of photoactive alkylphenols in discrete nuclei in brain slices (aim 2), and the in-vivo contribution o individual cells and networks to the hypnotic effects of alkylphenols. These latter studies will us fiberoptic laser stimulation of discrete regions of brain in live mice after systemic administratio of photoactive alkylphenols (aim 3). The three aims are integrated by their common prediction of molecular substrates arising from very different, complimentary and unbiased approaches. These studies will result in the identification of novel and plausible molecular substrates for alkylphenol action, which will serve as the basis for validation in subsequent proposals involving the construction of genetically altered animals. This collaborative project is ideally suited to integrate the neurobiological expertise of the Kelz lab with the electrophysiologic mastery of the Beck lab, and the biological chemistry prowess of the Eckenhoff and Dailey labs.

Public health relevance
PUBLIC HEALTH RELEVANCE: The injectable general anesthetics, typified by propofol, are being increasingly used in both surgery and noxious procedures, yet their mechanisms of action on all levels remain incompletely understood. We will deploy novel analogs of propofol, designed and synthesized in our labs, which can be activated by light to become exceptionally potent and durable, in a series of rationally tiered determinations of molecular, cellular and network substrates for this class of general anesthetic. This multidisciplinary campaign will result in knowledge that should allow development of anesthetics with an improved therapeutic ratio and side effect profile.